University of California, Davis: Human Papillomavirus Cancer Free (UCD: HPV Cancer Free)

This K01 award resubmission outlines an intensive five-year research career development program
focused on multilevel behavioral intervention and dissemination and implementation science research to
increase and sustain uptake of the human papillomavirus (HPV) vaccine. Supporting the candidate's career
and research goals is a mentoring team comprised of experts in behavioral intervention research, advanced
biostatistics methods, and dissemination and implementation science as well as a clinical expert panel.
Completion of the candidate's training plan and research study will provide the candidate with the experience,
skills, knowledge, mentoring and pilot data needed to become a leading independent investigator in
developing, implementing and evaluating multilevel behavioral interventions to reduce the burden of cancer in
racial/ethnic minority groups, starting with increasing HPV vaccination rates.
The HPV vaccine is a major public health breakthrough and is the optimal primary prevention strategy
against HPV-associated cancers. Widespread use of the HPV vaccine is expected to reduce the cancer
burden across all racial/ethnic group, as populations of color are disproportionately affected by HPV-
associated cancers. Despite CDC recommendations and the public health implications of full vaccination
coverage, HPV vaccine uptake among adolescents remains well below the Healthy People 2030 goal of 80%.
The National Immunization Survey reported that in 2019, only 54.2% of U.S. adolescents aged 13-17 were up
to date with the series. Preliminary data and a review of the literature suggest multilevel interventions that
address at least two levels influence show promise in increasing HPV vaccine uptake. The objective of this
proposal is to develop, implement and evaluate a multilevel (parent, primary care team, and clinic) intervention
aimed at raising adolescent HPV vaccination rates to the Healthy People 2030 goal of 80% for boys and girls
using a parallel group cluster randomized trial design. This study will assess the effectiveness of the multilevel
intervention on increasing the rates of HPV vaccination among patients aged 9-17 of a primary care network
and will identify barriers and facilitators for broad dissemination and implementation. This will be accomplished
through the following aims: 1) Refine and finalize a parent, primary care team and clinic ML intervention to
increase uptake and completion of the HPV vaccine series among adolescent patients of a primary care
network; and 2) Conduct and evaluate the effectiveness and sustainability of the ML intervention. The
proposed research is significant because it will contribute to the emerging field of HPV vaccination multilevel
intervention research and addresses the need for more scientifically rigorous, evidence-based interventions
that can be disseminated and implemented on a large scale. Successful adoption of widespread HPV vaccine
coverage programs will reduce racial/ethnic disparities in HPV-associated cancer by ensuring that the next
generation of Americans do not experience unnecessary deaths due to HPV-related cancers.

Public health relevance
The human papillomavirus (HPV) is a major public health threat that attributes to 34, 800 cancer cases annually in the United States, with the majority of these cases occurring in racial/ethnic minorities. Successful HPV vaccine coverage programs can reduce HPV-associated cancer disparities by ensuring that all populations are spared the morbidity and mortality due to HPV-related cancers. This proposal is relevant to the part of NCI's mission that pertains to leading the nation's research efforts to not only improve cancer prevention, but to also reduce disparities in cancer outcomes.